Omics Data Generation Center (ODGC) for the Acute to Chronic Pain Signatures (A2CPS) Program - A2CPS Extension Administrative Supplement

PROJECT SUMMARY
Chronic pain is a major health concern and one of the most common reasons adults seek medical care [1]. It is
associated with substantial morbidity linked to reduced quality of life, restricted mobility, depression, and opioid
dependence [2]. In 2016, approximately 50 million U.S. adults were afflicted with chronic pain, with approximately
40% of them having high-impact chronic pain [2]. The societal cost of chronic pain is estimated at $560 billion
annually in direct medical expenses, lost productivity, and disability programs [3]. The biological mechanisms
that prevent the resolution of acute pain after the initial insult and drive the transition from acute to chronic pain
are poorly understood [4,5]. The lack of rigorously validated biomarkers to predict which patients are more
susceptible to the transition from acute to chronic pain states is thus a major gap hindering the development and
implementation of population-wide and individualized preventive pain interventions [6]. The primary goal of this
project is to establish the A2CPS Omics Data Generation Center (ODGC) to generate genomic variant,
metabolomic, lipidomic, proteomic, and exRNA data from two pain cohorts consisting of 1800 subjects each,
with biofluid samples collected at baseline, 6 weeks, and 3 months after an acute pain episode. These samples
will be used to generate multi-omic data to validate 40 primary outcome biomarkers indicating susceptibility or
resilience to development of chronic pain, as well as to identify new candidate biomarkers.

Public health relevance
PROJECT NARRATIVE The primary goal of this project is to generate genomic variant, metabolomic, lipidomic, proteomic, exRNA, transcriptome, and microbiome data from two cohorts consisting of 1800 subjects each, with biofluid samples collected at 0, 3, and 6 months after an acute pain episode, which will enable validation of a pre-selected set of 40 primary outcome biomarkers for prediction of transition from acute to chronic pain, as well as discovery of new biomarkers. This project is relevant to public health because the ability to identify those at high risk of transition to chronic pain will enable the development of personalized approaches for prevention and treatment of chronic pain.